Language-specific and language-general mechanisms in bilingual aphasic individuals

PROJECT SUMMARY/ABSTRACT
Speaking multiple languages is the norm for the majority of the population of the world. However, research on
the neural bases of multilingualism has not been commensurate with the demographic relevance of this
population. In no small part, this has been due to the traditionally lower socioeconomic or immigrant status of
multilingual individuals. Consequently, there is a lack of fundamental knowledge about the organization and
interaction between languages in the bilingual brain. This lack of knowledge has appalling implications for
planning behavioral and surgical treatments for bilingual individuals with neurological disorders: it is currently
unclear which cortical tissue needs to be spared, and how much and how often each language should be targeted
to maximize recovered language function after brain damage in bilingual individuals. Thus, there is a critical need
to obtain a better understanding of how multilingual individuals’ languages are organized and how they interact
at different levels of representation to inform the development of strategies that maximize potential language
recovery after brain damage in a demographic group that will be the majority of the US population by 2040. The
proposed project will address this gap in knowledge by combining the study of aphasic and healthy Spanish-
English bilingual individuals in behavioral and fMRI tasks to create a symbiosis where theory and praxis mutually
inform each other. Specifically, the project will investigate the typology of deficits in post-stroke aphasic bilinguals
at the lexical level (i.e., single-word level; Aim 1A), and at the morphosyntactic level (i.e., how words are
combined into meaningful phrasal/sentential structures; Aim 1B) through the analysis of a spontaneous speech
corpus. The validity of the conclusions derived from these analyses will be tested and confirmed with tailored
behavioral experiments (Aim 1C). Aim 2 will target the neural bases of these processes through a combination
of voxel-based lesion-symptom mapping in post-stroke aphasic bilinguals (Aim 2A) and fMRI analysis of healthy
bilingual individuals (Aim 2B). Critically, by combining the study of a large speech corpus, targeted experimental
paradigms, and neuroimaging research, the proposed project holds the potential to obtain a comprehensive
characterization of bilingual individuals’ language organization across linguistic levels. This information will
constitute the first step to subsequently develop theoretically informed language recovery strategies, and
protocols tailored to the needs and characteristics of brain damaged bilingual individuals. Thus, the successful
accomplishment of the projects laid out in this proposal will establish the basis to develop strategies that
maximize potential language recovery after brain damage in a demographic group that will soon be the majority
of the US population. This award will also provide the candidate, who has a strong background in cognitive
neuroscience and electrophysiological methods, with critical training in patient testing and neuroimaging
methods, to promote a successful transition to an independent research career.

Public health relevance
PROJECT NARRATIVE A lack of basic knowledge about bilingual language organization prevents the adequate treatment of bilingual individuals after brain damage, leading to recovery rates that are well below those of their monolingual counterparts. The current project addresses this gap in our knowledge by testing healthy and aphasic bilingual individuals in behavioral and fMRI paradigms to identify the degree to which the cognitive and neural mechanisms that support bilingual language use are shared or distinct across languages and levels of linguistic representation. Obtaining this information constitutes a critical first step to potentially develop targeted intervention approaches that will maximize language recovery in post-stroke aphasia in a demographic group that will be the majority of the US population by 2040.